Cancer Risks from Unregulated Contaminants of Public Water Systems

PROJECT SUMMARY/ABSTRACT
Despite health protections of the Safe Drinking Water Act (SDWA), contaminants of concern continue to
emerge in public water systems (PWS). ‘Unregulated’ contaminants are addressed in the SDWA by the
Unregulated Contaminant Monitoring Rule (UCMR), which mandates sampling of PWS for a newly developed
list of unregulated contaminants of concern, every five years. The UCMR program, currently in its fifth cycle,
has identified contaminants in a systematic way across PWS that serve the majority of the U.S. population.
Several chemicals which were frequently detected in the UCMR are suspected or known carcinogens, such as
industrial chemicals 1,4-dioxane and per- and polyfluoroalkyl substances (PFAS) and metals including cobalt
and chromium-6. Disinfection byproducts also continue to be a major category of concern, even as water
treatment approaches change; for example, chlorate (a byproduct of chlorine dioxide disinfectant) was
detected in 69% of PWS in 2014-2016. The objective of this proposed study is to examine cause-specific
cancer mortality in relation to levels of unregulated contaminants in PWS. We will conduct our investigation
through linkage of individual survey records from one of the largest defined cohorts in the U.S. – the Mortality
Disparities in American Communities (MDAC) cohort from the U.S. Census Bureau – with measurement of
unregulated contaminants in PWS from UCMR sampling. Among U.S. adults in the MDAC cohort, over a study
period from 2008-2019, we will estimate associations between unregulated contaminants in PWS and cause-
specific cancer mortality. Drinking water contaminants will be examined both individually and as mixtures for
their associations with cancer mortality risks. Our study will be the first of its kind to leverage mandated PWS
monitoring results through linkage with individual-level cohort data in an examination of cancer risks from
unregulated drinking water contaminants. Given the geographic representation of our study to the U.S.
population, the size of the study population (>3 million adults), and the resolution of exposures to PWS service
areas, this project will provide a realistic overview of the contribution of particular unregulated contaminants on
cancer mortality and a high potential for translation to policy.

Public health relevance
PROJECT NARRATIVE Known and suspected carcinogens are frequently detected in U.S. public water systems. Examination of relationships between levels of these contaminants and cancer mortality risks in exposed communities will provide evidence needed for regulation to ensure safe drinking water.